Dynamics and heteromerization of PIEZO channel subunits

SUMMARY
The rapid detection of mechanical stress - and adaptation to it - is essential to all organisms. In vertebrates,
this task is mainly achieved by two homotrimeric ion channels called PIEZO1 and PIEZO2. Together, these
mechanosensitive channels transduce a rich diversity of mechanical forces, such as compression, vibration,
stretch, torque, and shear stress, into cellular signals that play essential roles across all physiological systems.
To date, it remains unclear how such a complex landscape of mechanical stimuli can be effectively transduced
by the two PIEZO mechanotransducers. In Aim1 of this exploratory proposal, we address this question by
testing the hypothesis that PIEZO1 and PIEZO2 subunits interact to form heterotrimeric channels, potentially
expanding the functional properties of PIEZO channels. To fulfill this aim, we will use bimolecular fluorescence
complementation (BFC), co-immunoprecipitation and electrophysiology. Our preliminary data reveals that,
when co-expressed in the same cells, the PIEZO1 and PIEZO2 subunits position their C-termini within
nanometric proximity, consistent with both subunits co-existing within the same channel. Co-
immunoprecipitation with validated antibodies will allow us to test whether wild-type PIEZO1/2 subunits also
interact. To test whether these heteromers consist of functional channels, we will use a novel functional BFC
approach (based on a split fluorescent calcium indicator) that we have created and validated. In Aim2, we will
test the hypothesis that different mechanical stimuli (including indentations, fluid shear stress, and osmotic
shocks) activate PIEZO channels through distinct conformational rearrangements of mechanosensory blade-
like domains. To this aim, we will measure intramolecular fluorescence resonance energy transfer (FRET) from
donor/acceptor probes genetically-inserted at strategic positions of adjacent PIEZO1 blades. Our preliminary
data shows that FRET efficiency decreases as a response to osmotic shocks. FRET will be measured using
epifluorescence, total internal reflection fluorescence and confocal imaging. We will determine if a correlation
exists between changes in FRET efficiency and the nature of the mechanical stimulus. If successful, this
exploratory R21 proposal will advance our fundamental understanding of mechanotransduction by mammalian
PIEZO channels, provide innovative research tools, and contribute to elucidating the molecular bases of force-
based therapeutic interventions.

Public health relevance
Narrative The human body senses and responds to an incredible diversity of mechanical stimuli, mainly through the activity of two homologous mechanosensitive ion channels called PIEZO1 and PIEZO2. To better understand how these two related proteins assume such a diversity of biological roles, we will test (1) whether the co-expression of PIEZO1 and PIEZO2 subunits promotes the formation of functional heteromeric channels, and (2) whether different types of mechanical stimuli activate PIEZOs through distinct rearrangements of mechanosensory domains. If successful, this work will shed light on molecular mechanisms underlying force-based manipulations for the treatment of pain and other ailments.